Wisconsin Multidisciplinary K12 Urologic Research Career Development Program

PROJECT SUMMARY
The University of Wisconsin (UW)-Madison Multidisciplinary Urologic Career Development Program (KURe) K12
began in 2013 to attract and retain aspiring scientists into the benign urologic research field. Our rich training
environment includes robust urologic research support including a George M. O’Brien Center in Benign Urology
Research; a Summer Program in Undergraduate Urologic Research (SPUUR); and a U24 interactions core
focused on Collaborating for the Advancement of Interdisciplinary Research in Benign Urology (CAIRIBU). The
K12 scholars and cadre of outstanding mentors also benefit from UW Madison’s NIH-funded Institute for Clinical
and Translational Research (ICTR) and an internationally recognized Center for Improvement of Mentored
Research Experiences. There has been tangible progress since 2013. In addition to five current scholars
receiving training, six scholars have completed K12 training and earned investigator-initiated NIH funding. Five
of these scholars are leading independent benign urology focused research programs as tenure track faculty at
research-intensive institutions. Building on proven success, the program will continue to recruit and retain
promising investigators through formative mentored research experiences and didactic training, as well as new
initiatives to enhance professional development, with the goal of expanding the workforce in benign urology
research.

Public health relevance
PROJECT NARRATIVE Building on a ten-year history of successful progress, the K12 training program will continue advanced training in clinical and basic science approaches and expand recruitment and training of scholars in population health and dissemination and implementation sciences in an environment that is ideally suited for professional skills development, building networking opportunities with researchers across the country, and matriculating independent researchers in benign urology with diverse expertise.